Functional Decline in Low Functioning Older Adults; Role of iron dysregulation

PROJECT SUMMARY/ABSTRACT
Preserving movement-related independence is a clinical and public health priority, as well as a major goal of the
National Institute on Aging and NIH’s strategic plan for research on aging. Our work has demonstrated that low-
functioning (LF) older adults have a more rapid functional decline than those who are high-functioning (HF).
The biological mechanisms that lead to accelerated functional decline in LF older adults remain poorly
understood, and few therapies are available to prevent its progression. As diverse as the etiologies of physical
disability are, a growing body of evidence strongly implicates the mitochondria (Mt) as playing a key role in the
initial onset and progression of functional decline in many individuals. Mitochondrial dysfunction has been directly
linked to accelerate telomere attrition, genome instability, epigenetic alterations, stem cell exhaustion, cellular
senescence, impaired proteostasis, and deregulated nutrient signaling, all key hallmarks of aging. What’s more,
perturbations in cellular and mitochondrial iron transport and handling may contribute to increased mutations
and deletions, which lead to a reduction in mtDNA copy numbers and thereby negatively affect mitochondrial
(Mt) function. Cellular iron import and export are critical for optimal cellular function. Iron levels are modulated
by the hormone hepcidin via binding and subsequent degradation of the iron export protein ferroportin (Fn). Iron
acquisition (import) occurs through transferrin receptor and is highly responsive to intracellular iron levels. We
also have documented increased skeletal muscle Mt iron stores which increased oxidative stress and the
susceptibility of Mt permeability transition pore (PTP) opening (a measure of Mt resiliency) with age.
Based on our pilot data our central hypothesis is that greater circulating hepcidin levels and muscle iron
deregulation (↓Ferroportin → ↑ Cellular and Mt Iron Levels → ↓TfR-1) in LF older adults will lead to Mt dysfunction
(↑Sensitivity to PTP, ↑Deletions/Damage, ↓Mitochondrial Respiration) and accelerated progression of functional
decline in LF compared to HF older adults.
To test our central hypothesis, we will conduct a prospective longitudinal study in which we will follow HF and LF
research participants (70 to 80 years) for 3 years and obtain plasma and skeletal muscle biochemical measures
of iron regulation and mitochondrial dysfunction at baseline and throughout the follow-up period. The Short
Physical Performance Battery (SPPB) will be used to classify LF (SPPB ≤ 9) and HF (SPPB > 10) participants.
We will annually assess the participants’ physical function through established measures (SPPB, 6-minute walk,
and muscle strength). We will assess changes in health behaviors, including activity levels, dietary intake, and
sleep at annual follow-up visits. For the proposed study, we will examine cross-sectional and longitudinal
associations of dysfunctional iron regulation with levels of Mt and physical function. If our hypotheses are correct,
results will be used to design clinical trials testing pharmacologic therapies that target hepcidin and muscle
abnormalities found to be associated with functional decline in LF older adults.

Public health relevance
NARRATIVE This study will be the first observational, longitudinal study to measure and compare over time biochemical measures in the circulation and skeletal muscle related to iron deregulation and mitochondrial dysfunction in both low-functioning and high-functioning older adults. The results from this study will help to identify cellular targets for future studies to improve iron homeostasis and mitochondrial function, which should ultimately slow the rate of progression of functional decline in older adults.